HIPC Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
The Human Immunology Project Consortium (HIPC) was founded in 2010 to create a network of independent
centers focused on measuring human immune responses with high-throughput systems immunology
approaches coupled with detailed clinical phenotyping. We propose to develop a HIPC Coordinating Center
(HCC) that will provide data more rapidly and effectively to the broader scientific community, and also serve the
entire HIPC by increasing the value of the research performed at HIPC Centers. In parallel, the HCC will serve
as a promoter of cross-HIPC collaborations through the organization of multi-center analysis projects and a
centralized Portal to provide a space for the exchange of ideas. Specifically, the HCC will continue the
development of shared data standards, provide a central Knowledgebase of study results, establish tools to
visualize and analyze data, lead synergistic cross-center analysis efforts, provide a Portal to make the tools and
data broadly accessible, and provide administrative support for the activities of HIPC subcommittees and
management of the Infrastructure and Opportunity Fund (IOF) program. Our team has proven experience in
running programs of similar scale and complexity. We also have the necessary familiarity with the HIPC network,
with our team including current PIs of the Data Standards IOF project, the Signatures IOF project, clinical
information capture, and the existing ImmuneSpace data portal. This proposal leverages this combined
experience and infrastructure while, in parallel, implementing various significant and necessary improvements
facilitated by the tighter integration and the 5-year time horizon of this dedicated HCC grant.

Public health relevance
PROJECT NARRATIVE Founded in 2010, the Human Immune Profiling Consortium (HIPC) has successfully brought together independent research centers to identify immune signatures associated with the outcomes of vaccinations and infections in humans. We propose to develop a HIPC Coordinating Center (HCC) that supports the HIPC network by providing a centralized Portal and Knowledgebase to facilitate data analysis and visualization, and to promote collaborations across the network by organizing subcommittees and cross-HIPC analysis projects.